PIMAGEDINE IN PATIENTS WITH TYPE II DIABETES MELLITUS AND DIABETIC NEPHROPATHY

The goal of the study is to evaluate the safety and efficacy of pimagedine, a nucleophilic hydrazine derivative, in preserving renal function in patients with type II diabetes mellitus and overt diabetic nephropathy. Parameters assessed include protein crosslinking, all- cause mortality, and cardiovascular mortality and morbidity.